Beyond BMI: Role of Body Composition, Coronary Microvascular Dysfunction and HFpEF in Characterizing Cardiometabolic Disease Phenotypes

PROJECT SUMMARY/ABSTRACT:
Obesity, coronary artery disease (CAD) and heart failure represent 3 of the most important threats to US public
health, yet there is limited understanding of how these chronic multimorbid conditions manifest differently across
heterogeneous populations, including women versus men. Ischemia with nonobstructive coronary arteries
(INOCA) captures a chronic condition that has newly emerged as a major contributor to adverse cardiovascular
disease (CVD) outcomes, especially in women. Current evidence suggests that a large proportion of these
women have coronary microvascular dysfunction (CMD). CMD is associated with increased risk of adverse CVD
outcomes, including death, myocardial infarction (MI), and heart failure with preserved ejection fraction (HFpEF),
especially in patients with obesity and cardiometabolic risk factors. Yet conventional diagnostic and therapeutic
strategies, tailored for identification and management of male-pattern obesity and CVD, miss a majority of these
at-risk women with INOCA, who represent an understudied population with high unmet clinical need. To optimally
address the heterogeneity of obesity in these patients, we propose to apply cutting-edge diagnostic technology
to investigate the role of body composition, CMD and HFpEF in characterizing adverse cardiometabolic
phenotypes in INOCA. The overall goal of this proposal is to leverage novel, sensitive multimodality imaging
tools to identify mechanisms of cardiometabolic risk in INOCA and clarify targets for future intervention in this
patient population. The PI is an Early Stage Investigator (ESI) cardiologist and expert in CMD ideally positioned,
together with Co-I experts in cardiothoracic radiology, artificial intelligence methods for body composition, and
clinical weight loss interventions, to build upon strong preliminary data and existing infrastructure from her NIH-
funded research to advance this time-sensitive, high-impact work in a manner that is scientifically significant,
clinically innovative, mechanistically plausible, and feasible for completion within the allotted time frame and
budget. Our central hypothesis is that phenotypic characterization of INOCA patients beyond body mass
index will yield important insights to understanding and treating this understudied cardiometabolic
condition. We will investigate the following specific aims: (1) to comprehensively assess novel body composition
metrics across lean and ectopic adipose tissue depots and identify their relationship to CMD in INOCA patients
using multimodal imaging with PET/CT, (2) to identify cardiometabolic pheonotypes in INOCA patients
associated with major CVD events, including death and hospitalization for MI and HFpEF, and (3) to evaluate
the impact of serial clinical weight loss interventions (GLP-1 agonist and bariatric surgery) on body composition,
coronary microvascular function, myocardial strain and cardiorespiratory fitness in patients with INOCA and
severe obesity. By rigorously characterizing body composition, CMD and HFpEF risk in INOCA, the proposed
aims will definitively clarify our understanding of this understudied condition overrepresented in women and tailor
novel discovery to exert a sustained, powerful influence on obesity/cardiometabolic health research.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE: Obesity, coronary artery disease and heart failure represent three of the most important threats to US public health today, yet there is limited understanding of how these chronic multimorbid conditions manifest differently across heterogeneous populations, including women versus men. Ischemia with nonobstructive coronary arteries (INOCA) captures a chronic condition that has newly emerged as a major contributor to adverse cardiovascular disease outcomes, especially in women, but its underlying mechanisms are not well understood. We propose to leverage multimodality imaging tools including PET/CT and cardiopulmonary exercise testing to investigate the role of body composition, coronary microvascular dysfunction and heart failure with preserved ejection fraction in characterizing adverse cardiometabolic phenotypes in INOCA beyond body mass index, address the heterogeneity of obesity, and clarify targets for future intervention in this understudied patient population with high unmet clinical need.